BACTERIAL TRANSCRIPTION COMPLEXES

This proposal addresses transcription initiation, elongation, and termination by bacterial RNA polymerase (RNAP).
In transcription initiation, RNAP: (i) binds to promoter DNA, yielding an RNAP-promoter closed complex; (ii)
unwinds promoter DNA, yielding an RNAP-promoter open complex; (iii) synthesizes the first -11 nucleotides of
RNA as an RNAP-promoter initial transcribing complex, using a "scrunching" mechanism in which RNAP remains
stationary on promoter DNA and pulls in adjacent DNA in each nucleotide-addition cycle; and (iv) escapes from
the promoter. In transcription elongation, RNAP synthesizes the remaining nucleotides of RNA as an RNAP-DNA
elongation complex, using a "stepping" mechanism in which RNAP moves forward on DNA in each
nucleotide-addition cycle. In transcription termination, RNAP stops synthesizing RNA, releases RNA, and
dissociates from DNA. Each of these reactions is a target for regulators. Understanding transcription initiation,
elongation, termination, and regulation will require defining the structural transitions in protein and DNA in each
reaction, the kinetics of structural transitions, and the mechanisms by which regulators affect structural transitions.
In the current period, we defined the structural basis of transcription start-site selection, de nova transcription
initiation, non-canonical-initiating-nucleotide-dependent transcription initiation, initial transcription, and Class 11
transcription activation; we developed high-throughput-sequencing approaches that enable comprehensive
analysis of DNA-sequence determinants for transcription; we developed multiplexed crosslinking approaches that
enable comprehensive analysis of protein-DNA interactions in transcription; we developed ensemble and
single-molecule fluorescence assays that enable monitoring of RNAP clamp and RNAP trigger-loop conformation
in solution; and we defined binding sites and mechanisms for small-molecule inhibitors of transcription.
The proposed work will build on the findings of the current period. The proposed work will use x-ray
crystallography, single-molecule biophysics, biochemistry, and genetics to address five specific aims:
Specific Aim 1: Determination of the structural basis of RNAP slippage
Specific Aim 2: Determination of the structural basis of RNAP translocation
Specific Aim 3: Analysis of RNAP translocation in elongation, pausing, and termination
Specific Aim 4: Analysis of RNAP clamp conformation in elongation, pausing, and termination
Specific Aim 5: Analysis of RNAP triqqer-loop conformation in elonqation, pausinq, and termination
RELEVANCE (See instructions):
Bacterial RNA polymerase (RNAP) is a molecular machine that carries out reactions essential for bacterial gene
expression and bacterial growth. Two classes of current antibacterial drugs function by inhibiting RNAP. The
proposed work will provide information essential for understanding the mechanism of action of RNAP and for
rational design of improved and novel antibacterial drugs that function by inhibiting RNAP.